BU Summer Institute for Research Education in Biostatistics and Data Science

ABSTRACT
Boston University (BU) proposes a comprehensive program entitled the `Boston University Summer Institute for
Research Education in Biostatistics and Data Science' (BU SIBS) that includes biostatistical analysis,
epidemiology, infectious disease modeling, design and analysis of clinical trials, statistical genomics, and
statistical computing within a data science framework. The structure includes online modules preceding a five-
week in-residence program followed by additional remote work on a mentored group research project. The
rigorous curriculum is interspersed with current examples highlighting the relevance of biostatistics with particular
emphasis on biomedical big data, machine learning approaches, and high performance computing. BU SIBS is
designed to interest and engage a diverse group undergraduates, recent graduates and early graduate students
from across the US. Our faculty is enthusiastic and committed, as are our guest speakers who are practicing
data scientists, biostatisticians, epidemiologists, and physician-scientists from academia and industry. Hands-
on analyses with teaching data sets from the National Heart, Lung, and Blood Institute's (NHLBI) Framingham
Heart Study and Jackson Heart Study, along with relevant COVID-19 and tuberculosis examples, reinforce skills
in computing, data visualization, statistical and computational modeling, and interpretation of findings while
deepening exposure to a central theme of health inequities. The typical daily schedule will include a morning
lecture with incorporated R programming examples and active learning exercises. After lunch at the BU dining
facilities participants will return to the computer classroom to complete short assignments either relevant to the
lecture content or focused on new computing skills (SAS/Linux) or to work on the group research project. The
research project will span the entire program and will deeply engage students in a content area. Working with a
research mentor, the students will determine a research question, develop an analysis plan and proposal,
conduct the analysis, and synthesize and present results. The daily schedule will be interspersed with guest
speakers and site visits (e.g. to the Framingham Heart Study). Multiple sessions on career paths and graduate
school are also included. Strong institutional support from BU provides a 50% tuition scholarship, teaching
assistants, and infrastructure to support all aspects of student life during the program. BU has run a Summer
Institute in Biostatistics (BU SIBS) since 2004. Our track record is very strong. We successfully maintain follow
up of 92% of our BU SIBS alumni (2004-2020) and ~65% of our prior participants have either entered into
graduate programs in biostatistics or a closely related discipline or taken jobs in the field. Our experience with
our prior BU SIBS programs will enable us to rapidly implement a new BU SIBS program, maintaining proven
aspects of our past program while introducing new elements including a data science framework, an expanded
infectious disease module, stronger health inequities emphasis, and a more in depth research experience.

Public health relevance
The Boston University Summer Institute for Research Education in Biostatistics and Data Science (BU SIBS) is a five-week in-residence program, followed by a period of continued remote research, designed to build skills and to interest undergraduates, recent graduates and early graduate students in the many exciting opportunities in the field of Biostatistics. The trainees’ future role in public health will be enhanced due to their early exposure to the foundations of biostatistical analysis, epidemiological analysis, infectious disease modeling, design and analysis of clinical trials and statistical genetics analysis within a data science framework.